Universal Test and Connect: A Pilot Study of Comprehensive HIV Service Delivery in Emergency Care Settings in South Africa

PROJECT SUMMARY
South Africa continues to shoulder the highest burden of people living with HIV (PLHIV) in the world. In an
effort to minimize the national burden of the HIV epidemic, South Africa has been at the forefront of adopting
biomedical prevention. Still there is work to be done, as key populations (vulnerable patients, young men and
women) are still not accessing lifesaving preventative and therapeutic HIV services. The ED provides care to
high volumes of adults who may not otherwise interact with the health system, and thus is an important testing
and linkage to care venue. A Universal Test-and-Connect (UTC) strategy promotes access to both
preventative (pre- and post-exposure prophylaxis) and therapeutic (ART initiation) HIV services from the ED. It
can expand care to otherwise missed populations and aligns directly with a differentiated service delivery
model that is integrated within existing, sustainable service delivery venues. This status neutral approach has
the ability to normalize HIV services in a venue that is untouched but shows great promise.
The goal of this R34 proposal is to integrate UTC in two high volume EDs (one a high-volume tertiary care
trauma center and another a high-volume district level facility) in Cape Town, South Africa. We first aim to
integrate HIV assessment over a period of one year into routine care to define the prevalence and key
characteristics of ED patients eligible for UTC interventions (Aim 1). We then seek to pilot (N=100) the delivery
of oral and long-acting pre-exposure prophylaxis (PrEP) to ED patients (Aim 2). This has never been trialed
before in the ED context in South Africa, and we seek to determine the preliminary uptake of PrEP (oral and
long acting) in ED patients, as well as PrEP continuation at six weeks. Lastly, we propose to determine the
operational feasibility of UTC using value stream mapping to map patients journeys in the ED and determine
healthcare worker acceptability using the normalization process theory framework to guide physician and
nursing surveys (N=160) and in-depth interviews (N=40).
This new collaboration between Johns Hopkins University and the Desmond Tutu HIV Foundation brings
together our complementary expertise in ED-based HIV service delivery and action research to reach missed
populations. Together we seek to deliver the ED as an untapped partner in the fight against HIV, so that all
populations can access life changing preventative and therapeutic HIV services.

Public health relevance
PROJECT NARRATIVE The goal of this proposal is to pilot an integrated HIV service delivery intervention using a status neutral strategy in two emergency departments (ED) in South Africa. Given the high burden of HIV and people at high risk of HIV acquisition in the ED, we seek to integrate HIV testing, and pilot the provision of oral and long- acting pre-exposure prophylaxis (PrEP) to ED patients. We seek to understand the impact of these innovations on ED flow, and assess the feasibility for long term adoption of this strategy in the ED.